Multi-organ omic model for sepsis therapeutic development

ABSTRACT
Sepsis-3 is defined as life-threatening organ dysfunction caused by the body’s dysregulated host response to
an infection. An early feature of sepsis is the dysregulated activation of endothelial cells, which initiates a
cascade of inflammatory signaling events by releasing various mediators, leading to leukocyte adhesion,
migration, tissue damage and multiple organ dysfunction syndrome (MODS) if left uncontrolled. To date,
therapeutic approaches for the treatment of sepsis are largely supportive, but there are no specific
pharmacologic therapies available that protect from endothelial cell dysfunction. All sepsis drugs recently
developed in rodents have failed in clinical trials, in large part because of the differences in species and the
diverse phenotypes of endothelial cells demonstrating heterogeneity in function, morphology and omic
expression patterns. Novel methods leveraging recent developments in omics are therefore needed to
investigate how this heterogeneity impacts response to therapeutics in sepsis. In this project, I will employ omic
and in silico models to investigate the role of specific protein targets in sepsis progression. Our group has
identified Protein Kinase C-Delta (PKCδ) as a critical regulator of the inflammatory response, and I will use my
model to determine the role of PKCδ in the progression of inflammatory signaling in human lung, liver and kidney
endothelium in sepsis. Overall, these studies will help identify druggable/therapeutic targets that will then be
experimentally validated using our novel microphysiological assay (MPA). I hypothesize that my proposed
comprehensive, in silico proteomics model and corresponding validation experiments in our MPA will
provide unique insight on the role of protein targets in predicting physiological responses in humans
under septic and normal conditions. Our long-term goal is to develop a methodology to rationally design
therapeutics for treating sepsis. The specific aims of my study are to 1) Create a comprehensive, in silico
proteomics model to predict physiological responses in humans under septic and normal conditions and 2) Use
a novel MPA to validate the role of the protein targets as predicted in Aim 1. These synergistic studies will focus
on the role of the endothelial cell heterogeneity in sepsis, and the role of PKCδ and other protein targets in
regulating the endothelial cell response in sepsis using an in silico model and an MPA employing human
endothelial cells, and leukocytes and plasma from septic patients and healthy subjects to increase translatability
in therapeutic development.

Public health relevance
PROJECT NARRATIVE Sepsis-3 is defined as life-threatening organ dysfunction due to a dysregulated host response to infection. I will develop a comprehensive, in silico proteomics model and validate it experimentally in our microphysiological assay (MPA). This platform will then be used for screening anti-inflammatory therapeutics and identifying druggable targets and pathways in sepsis.